TREATMENT OF OSTEOPOROSIS WITH DICLOFENAC SODIUM

Previous studies suggest prostaglandins (PGE) mediate postmenopausal bone loss: synthesis of PGE2 by cultured neonatal rat calvaria is increased by ovariectomy and is decreased by 17 Beta-estradiol. Studies were conducted to determine in postmenopausal bone loss, reflected by increases in urinary N-telopeptide, a marker for bone resorption, can be prevented by the NSAID Diclofenac Sodium.